Contingency management plus deep transcranial magnetic stimulation for the treatment of cocaine use disorder

PROJECT SUMMARY
The prevalence of cocaine use disorder (CUD) in the United States is increasing, now affecting approximately
1.4 million, alongside a significant rise in the rate of cocaine-involved overdoses. In the absence of FDA-
approved medications, treatment options for CUD are limited to behavioral approaches, with Contingency
Management (CM) considered the most effective. However, research by our group and others has shown that
responses to CM vary considerably, with poorer treatment outcomes associated with phenotypic characteristics in
the domains of cognition, reward, and negative emotionality. This study aims to develop a novel treatment
combination by pairing behavioral therapy (CM) with transcranial magnetic stimulation (TMS) that targets brain
circuity alterations associated with CM effects, with the goal of improving treatment refractoriness. Basic behavioral
neuroscience research has indicated that the anterior insular (AIn) – amygdala pathway plays a key role in
psychostimulant abstinence and relapse in rodent models of CM. Until recently, traditional TMS devices could
only stimulate a focal area directly under the skull. Recent advances in brain stimulation techniques allow for
targeting these deeper structures. Specifically, the ‘deep TMS’ H4 coil stimulates the insula and lateral
prefrontal cortex (PFC) bilaterally, making it possible to target CM-critical pathways. Further, the insula and
PFC are critical hubs for cognition, reward, and negative emotionality phenotypes associated with CM, such
that H4-delivered TMS could potentially correct these phenotypic characteristics linked to treatment
refractoriness. This study will use a novel two-stage design to evaluate the effects of CM plus H4 TMS for
treating CUD. In the first 4 weeks of treatment, all participants (n = 130) will receive high-magnitude CM to
identify treatment refractoriness, with initial ‘response’ to CM defined as achieving two weeks of consecutive
cocaine-negative urines. Participants who do not respond (‘non-responders’) will enter the TMS augmentation
protocol and be randomized to receive either active or sham deep H4 TMS therapy, in addition to CM, for
another 8 weeks. The accelerated TMS protocol will consist of three sessions of intermittent theta burst
stimulation (iTBS), delivered thrice weekly for six weeks then once weekly for two weeks. Primary outcomes
will include abstinence (proportion of responders), reduced cocaine use (percent negative urines), and change
in craving as assessed through self-report and cue-induced electroencephalogram brain responses (Aim 1).
Resting-state functional connectivity (rsFC) and the NIDA Phenotyping Assessment Battery (PhAB) will be
conducted at three timepoints to explore treatment mechanisms associated with the proposed pathway (Aim
2). Machine learning techniques will integrate data across modalities (rsFC; PhAB) to preliminarily develop a
predictive model aimed at identifying initial non-responders who are most likely to benefit from CM+TMS
treatment (Exploratory Aim). If successful, the results of this study could pave the way toward FDA clearance
of a combination (CM+TMS) product tailored to individuals with treatment-refractory phenotypes.

Public health relevance
PROJECT NARRATIVE While Contingency Management is the most effective evidence-based behavioral treatment for cocaine use disorder, the majority of patients do not respond. Advances in neuromodulation techniques, including `deep transcranial magnetic stimulation' (TMS), now allow for stimulation of key circuitry thought to underlie Contingency Management effects. This project aims to develop a safe and effective combination behavioral and neuromodulation treatment that has the potential to significantly improve outcomes in treatment-refractory patients.